Core 3. Ocular Mass Spectrometry, Lipidomics, and Proteomics Core (OMSLPC)

Summary
The Ocular Mass Spectrometry, Lipidomics, and Proteomics Core will provide equipment and expertise for the
mass spectrometric analysis of ocular tissues. The Core will provide equipment for the analysis of ocular proteins,
metabolites, lipids and other small molecules, train laboratory personnel and assist in the planning and analysis
of experiments, and maintain existing instrumentation.

Public health relevance
Project Narrative Not require per FOA.